Differential impact of acute and chronic opioids on ocular innate immunity and infections

Project Summary
Opioid Use Disorder (OUD) poses serious consequences including overdose or death from excessive and
prolonged use of prescribed or illicit opioids. The opioid epidemic has also resulted in a striking, nationwide
increase in infectious diseases including HIV, hepatitis, and invasive bacterial and fungal infections, which
worsen long-term health outcomes. The consensus is that opioids are immunosuppressive and thereby
increase the vulnerability to infections. However, the effect of acute or repeated opioid exposure on immunity
remains elusive. In the eye, substance use is an important risk factor for developing endogenous
endophthalmitis, a blinding infectious disease primarily caused by fungal (Candida sp.) and bacterial (S.
aureus) pathogens. Several clinical and epidemiological studies have reported an increasing number of opioid
use-associated endophthalmitis cases. Our preliminary data showed that cultured human retinal pigment
epithelium (RPE) cells, human monocytes, and mouse retina express the mu-opioid receptor (MOR) which is
activated in response to morphine exposure. Acute morphine exposure increased, whereas repeated morphine
exposure decreased, inflammatory response in cultured cells. Similarly, repeated morphine administration in
B6 mice reduced cytokine levels in the plasma but elevated them in the retinal tissue. Additionally, systemic
Candida auris infection in morphine-dependent mice increased fungal burden in the eye, brain, and kidneys.
Based on these findings, we hypothesize that repeated opioid exposure (e.g., morphine and fentanyl) impairs
both systemic and ocular innate immunity resulting in increased incidence and severity of infectious
endophthalmitis. The overall goal of this proposal is to evaluate the effect of opioids on innate immunity and its
impact on the pathogenesis of endophthalmitis. Here, we will elucidate mechanisms underlying impaired innate
responses of retinal and myeloid cells under opioid exposure (Aim 1) and determine whether OUD increases
the susceptibility and severity of endophthalmitis in mouse models (Aim 2). The knowledge gained from this
study could have a significant impact on ocular infections among substance abusers and could contribute to
the advancement of therapeutic interventions in the field, offering new hope for preserving vision and improving
outcomes in patients affected by these conditions.

Public health relevance
Project Narrative Opioids are commonly prescribed for pain management but with repeated use their analgesic benefits diminish (tolerance) and can lead to hyperalgesia and physical dependence, making it difficult to discontinue opioid use. Substance use, including opioids, is an important risk factor for developing endophthalmitis, a blinding infectious disease primarily caused by fungal (Candida sp.) and bacterial (S. aureus) pathogens. This study aims to investigate whether opioid exposure increases the susceptibility and/or severity of endophthalmitis and determine the underlying mechanisms.